Biocomputation of the Links Between Muscle Morphology, Coordination and Injury

DESCRIPTION (provided by applicant): Muscle strain injuries are one of the most common conditions seen in sports medicine clinics. However, methods of treatment are variable and re-injury rates tend to be high which, in part, reflects a lack of fundamental understanding of the factors that influence injury risk. The prevailing theory is that injury occurs as a result of excessive strain of active muscle fibers. The goal of this study is to develop novel biocomputational tools to predict and analyze the strain distributions within skeletal muscles during movements associated with injury. Model predictions will be compared with strain measures obtained using state-of-the-art dynamic magnetic resonance imaging experiments. Once validated, we will use the biocomputational tools to investigate how morphology and coordination influence hamstring injury risk during running. Following are the specific aims. Aim 1 will use a dynamic magnetic resonance imaging technique to measure the strain distributions within the individual hamstring muscles during lengthening contractions, a loading condition commonly associated with injury. Comparisons between muscles will provide new insights into the propensity for hamstring injury to occur in the biceps femoris long head. Aim 2 will build a biocomputational framework to predict muscle strain distributions during movement. The framework will couple finite-element simulations of muscle tissue behavior with dynamic simulations of whole body movement. The methods will be validated by comparing strain predictions with those determined from the dynamic images in Aim 1. We will then use the framework to investigate the relationship between muscle excitations, hamstring tissue strains and skeletal movement during running. Aim 3 will evaluate whether computational models predict re-injury prevention strategies. We will build and validate models of subjects who exhibit residual changes in tissue structures as a result of a previous hamstring injury. We will then use the software framework to identify how movement coordination can be adapted to accommodate injury-induced changes in morphology. This research will establish a biocomputational framework that reveals the complex relationship between muscle morphology, coordination and injury risk, thus providing a new paradigm for identifying rehabilitation and injury prevention strategies. Muscle strain injuries are one of the most common conditions seen in sports medicine clinics. However, methods of treating muscle injuries are variable and re-injury rates tend to be high. This proposal couples novel biocomputational tools and imaging techniques to establish a scientific basis for preventing and rehabilitating hamstring muscle injuries.

Public health relevance
PROJECT NARRATIVE Tendon injuries are extremely common in the workplace and sporting activities. This study develops and evaluates advanced ultrasound imaging technologies for assessing tendon mechanics and structure. The technology has the potential to improve the understanding of the biology, healing and repair of tendon, and could provide a quantitative means for assessing the onset and progression of injury, and outcomes of treatment.